Primary Immunodeficiency Research Consortium

The Primary Immunodeficiency Diseases Consortium (l) provides leadership and mentoring;facilitates collaborations;enhances coordination of research efforts;and solicits, reviews, and makes awards for pilot or small research projects;(2) maintains a primary immunodeficiency diseases registry, which provides data to the research community about the clinical characteristics and prevalence of these diseases;and (3) develops a repository of specimens from subjects with primary immunodeficiency diseases. The Consortium funds research proposals and continues to review new proposals 3 times each year.